Project 4 Dissecting the Role of Revival Stem Cells and Tuft Cells in the Radiation-Induced Gastrointestinal Syndrome to Define Targets for Mitigation

In the event of a radiation disaster or attack, high dose radiation exposure to humans causes Acute Radiation
Syndrome (ARS). The hematopoietic system and gastrointestinal (GI) tract are among the most vulnerable
tissues to radiation injury due to the presence of cycling stem cells that are sensitive to radiation. Loss of
regenerative capacity in these organs leads to lethal toxicity. For example, damage to the bone marrow from
total body irradiation leads to the hematopoietic syndrome. High doses of radiation to the abdomen results in
GI syndrome characterized by damage to the intestinal epithelium, loss of mucosal barrier, and sepsis. While,
medical countermeasures to mitigate the hematopoietic syndrome are available, there are currently no FDA
approved therapies to mitigate the GI syndrome.
We have demonstrated that p53 mediated expression of the cell cycle inhibitor p21 in GI epithelial cells is
critical for survival of the GI syndrome. High p21 expression prevents damaged cells from progressing through
mitosis and succumbing to mitotic catastrophe. In contrast, radiation kills p21-low, fast cycling LGR5+ GI stem
cells in the base of the crypts. When these cells are lost, regeneration of the intestinal epithelium is dependent
on a slow-cycling, and thus radioresistant, cell population that resides higher in the crypt. Therefore, identifying
the GI epithelial cell type that is preserved by high p21 expression and capable of supporting tissue
regeneration following injury will be important for developing mitigation strategies for GI syndrome.
Recently published single cell RNA sequencing data from irradiated small intestine epithelial cells in mice
identified Clu+ revival stem cells as slow cycling cells with high p21 levels that survive 24 hours and proliferate
after high dose irradiation. Clu+ cells are capable of regenerating LGR5+ stem cells after injury and loss of this
cell type sensitizes mice to GI syndrome lethality. Clu+ cells rely on the Yap1/Hippo signaling axis for
maintenance and therefore we hypothesize that modulation of this pathway will mitigate the GI syndrome. In
addition, Dclk1+ tuft cells were also identified to have high p21 expression and survive high dose radiation.
These cells are chemosensory and secretory cells that support renewal of the GI epithelium following
irradiation by maintaining the stem cell niche. We hypothesize that p53 regulation of p21 in these cell types is
critical to intestinal recovery following radiation injury and that targeting these cells for mitigation is a promising
strategy. We propose to dissect the mechanisms by which Clu+ revival stem cells and Dclk1+ tuft cells function
to promote renewal of the GI epithelium after radiation injury using sophisticated genetically engineered mouse
models. We will use targeted approaches with small molecule drugs in vivo and CRISPR/Cas9 screening
methods in organoid cultures to identify novel mitigator targets that function specifically in these cell types to
reduce lethal GI toxicity.

Public health relevance
Relevance Statement The proposed research is relevant to public health because (1) it aims to develop novel countermeasures against radiation with efficacy at 24 hours after radiation exposure and (2) it aims to define the mechanisms of action of the countermeasures which would provide data necessary for FDA approval of a drug according to the Animal Rule. Therefore, this research has the potential to lead to the approval of a new mitigator of the acute radiation syndrome, which is relevant to the part of the National Institute of Allergy and Infectious Disease’s mission to support research that develops countermeasures against radiation injury.